South Carolina Cancer Disparities Research Center (SC CADRE)

SUMMARY .
ABSTRACT
N/A. Description is included in the original proposal.

Public health relevance
PROJECT NARRATIVE . N/A. Description is included in the original proposal.